Pathogenesis of staphylococcal biofilm-related infection

In FY 2021, we continued our efforts to understand biofilm-associated infection and associated bacteremia by coagulase-negative staphylococci and Staphylococcus aureus. We performed analysis of sepsis caused by coagulase-negative staphylococci, S. haemolyticus and S. aureus in addition to S. epidermidis. This research addresses one of the most frequent and severe complications of biofilm formation on indwelling medical devices by staphylococci. In collaboration with Dr. Li in Shanghai we continued our research on the role of S. epidermidis biofilm formation in probiotic bacterial interaction in the nose and on the skin and during allergic rhinitis.